HHV8 VIRAL LOAD IN KAPOSI'S SARCOMA

The purpose of this research study is to help determine the cause(s) of Kaposi's sarcoma by analyzing Kaposi's sarcoma tissue. These analyses will include measurements of the effect of a substance (Tat) produced by Human Immunodeficiency Virus infected cells on Kaposi's sarcoma.